Endothelial Cell SR-BI Regulation and Novel Protein Partners in Atherosclerosis

Project Summary/Abstract
Atherosclerosis underlies life-threatening cardiovascular disorders such as myocardial infarction and
stroke. We previously discovered that scavenger receptor class B type I (SR-BI, encoded by Scarb1) drives LDL
transcytosis in endothelial cells, delivering LDL to the subendothelial space where its accumulation by
macrophages promotes atherosclerosis. We recently determined by single cell RNAseq in human coronary
arteries that SR-BI is upregulated in endothelial cells associated with atheromas versus in cells from segments
lacking atheroma. Gene signatures for responses to varying blood flow revealed that disturbed flow may also
upregulate SR-BI. We have revealed that endothelial SR-BI is upregulated in mice with either
hypercholesterolemia or disturbed blood flow induced by carotid artery partial ligation. Using mass spectrometry
and LDL transcytosis assays, we have determined that the E3 ligase c-Cbl and the Zn transporter ZIP10 interact
with SR-BI and are required for LDL transcytosis via mechanisms likely shared with the receptor. Springboarding
from these discoveries, the Overall Goal of the proposed research is to determine how endothelial SR-BI
expression is regulated in vivo, and how SR-BI partners with other proteins to mediate LDL transcytosis. Aim 1
will determine how hypercholesterolemia and disturbed blood flow upregulate endothelial SR-BI. Transcription
factor networks derived from the coronary endothelial cell RNAseq reveal parallel upregulation of HIF-1α and
SR-BI and possible regulatory interaction in the setting of atheroma formation or disturbed flow. Using ChIP-seq,
CHIP-qPCR and CRISPR, we have identified HIF-1α binding sites in intron 1 of human Scarb1 and 28kb 5’ of
mouse Scarb1 that mediate HIF-1α upregulation of SR-BI. We will test the hypothesis in mouse models that
there is a unifying mechanism in which HIF-1α mediates endothelial cell SR-BI upregulation by
hypercholesterolemia and by disturbed blood flow to promote endothelial cell LDL uptake and atherosclerosis.
Studies will include a test of the impact of CRISPR-based excision of the HIF-1α binding site 5’ to mouse Scarb1
in endothelium. Aim 2 will determine how the new partner proteins c-Cbl and ZIP10 modulate LDL transcytosis
by SR-BI. In culture we will use mutagenesis to identify the specific functions of c-Cbl and ZIP10 and modes of
SR-BI interaction required to govern LDL transcytosis. In vivo studies will determine how endothelial cell
knockdown of c-Cbl or ZIP10 impacts artery LDL uptake and atherosclerosis. Guided by the findings in culture,
using nanoparticles to reconstitute endothelial cell genes in mice, in vivo structure-function studies will be done
of SR-BI interaction with c-Cbl or ZIP10 and their specific functions. Aim 2 will test the hypothesis that via
discrete capacities and interactions with SR-BI, c-Cbl and ZIP10 partner with SR-BI to invoke artery wall LDL
delivery and atherosclerosis. By accomplishing these Aims and unraveling how endothelial SR-BI expression is
regulated and how SR-BI works with partner proteins to drive endothelial LDL transport, it is expected that novel
therapies can then be developed to disrupt SR-BI-mediated artery entry of LDL for cardiovascular benefit.

Public health relevance
Project Narrative Atherosclerosis underlies life-threatening cardiovascular disorders such as heart attack and stroke, and we previously discovered that a specific protein in blood vessel lining cells binds LDL to carry it into the artery wall to cause the atherosclerosis. We recently found that the amount of the protein in the lining cells is increased by high cholesterol or turbulent blood flow, and that it has partner proteins required for the LDL transport. The proposed research program will determine how the abundance of the protein is regulated by high cholesterol or turbulent blood flow, and how the partner proteins work with it to participate in atherosclerosis development.